EFFECT OF EXERCISE ON PEAK BONE MASS IN YOUNG ADULT WOMEN

To determine if exercise increases bone density of young women and to determine if total and regional bone density differs between athletes involved in regular weight-bearing exercise and those in non-weight bearing exercise.